The interplay of the heat shock cascade and Rett syndrome

PROJECT SUMMARY / ABSTRACT
Rett syndrome (RTT) is a neurodevelopmental disorder that is associated with loss-of-function mutations in the
Methyl CPG Binding Protein 2 (MeCP2) gene. MeCP2 is a methyl-reader protein that forms a bridge between
methylated DNA and larger chromatin structure. As a result, mutations in MeCP2 result in the disruption of
thousands of genes, making it difficult to identify those that are pathogenic and those that are transcriptional
noise. Traditionally, RTT is first diagnosed clinically and then confirmed through the identification of mutations in
the MECP2 gene. However, ~5% of RTT patients are found to be MeCP2-mutation-negative (atypical RTT),
despite sharing overlapping symptomology with typical RTT. We hypothesized that genes with conserved
disruption in typical and atypical patient populations would identify those most critical to their shared clinical
presentation. Using a cohort of 44 autopsy samples from RTT patients, we identified 5 that were MeCP2-
mutation-negative. We then conducted differential RNA sequencing on these samples relative to 6 typical RTT
samples and 9 neurotypical controls. These experiments revealed that pathways associated with heat shock
(HS) signaling are dramatically elevated in both populations. When we assessed all 44 autopsy samples,
elevated HS signaling was enriched in typical RTT patients with severe, truncating mutations and not mild,
missense mutations. As both patient groups exhibited the same protracted death process, the differential
expression of HS proteins suggests that it is not an artifact, but rather a bona fide component of RTT. We
hypothesize that increased HS signaling contributes to severe phenotypes in RTT, and we will test this
hypothesis in Aim 1 by 1) genetically diminishing the HS response (HSR) from conception in a mouse model of
RTT to assess whether phenotypes become milder, and 2) pharmacologically normalizing the HSR to determine
whether it rescues existing phenotypes. Mechanistically, MeCP2 is known to regulate baseline gene expression
by controlling the rate of transcriptional initiation. We hypothesize that MeCP2 regulates the expression of
activity-dependent genes, like HSPs, in an identical manner. In Aim 2 we will first determine the scope of gene
disruption following thermal stimulation using RNA-seq (Aim 2a), and then mirror those experiments with Pro-
seq on mice treated with the elongation inhibitor flavopiridol (Aim 2b). Together, these experiments will identify
which stress response genes are affected by the loss of MeCP2, and establish whether their change in
expression is associated with impairments in transcriptional initiation, thereby providing a mechanistic
complement to the therapeutically relevant experiments outlined in Aim 1. This proposal has been designed to
provide extensive training in neuropharmacology, behavioral neuroscience, and bioinformatics which I have
identified as critical for my career development. My mentors and I have developed a training plan composed of
didactic and technical training to prepare me for an independent career in academic research.

Public health relevance
PROJECT NARRATIVE Differential RNA-sequencing of temporal cortex autopsy samples from typical and atypical forms of the neurodevelopmental disorder Rett syndrome (RTT) has uncovered elevated heat shock signaling as a highly conserved aspect of the disease. Here we describe a strategy to delineate whether inhibition of HS signaling is therapeutic through genetic and pharmacological manipulation of the HS response in mouse models of RTT and determine the underlying mechanisms driving cellular stress responses. We posit that our findings may uncover novel mechanisms for RTT pathogenesis which will aid in drug-discovery efforts for the disorder.